University of Southern California Alzheimer’s Disease (AD) and Alzheimer’s Disease-Related Dementias (ADRD) Resource Center for Minority Aging Research (USC AD/ADRD RCMAR)

PROJECT SUMMARY – ANALYSIS CORE
The health, social and economic issues associated with dementia, and the inequitable burden of dementia across
different racial/ethnic populations, are of such magnitude and complexity that they require a vantage point from
multiple disciplines. Generating scientific evidence to advance dementia health equity requires rigorous methods
applied to the best available data. The University of Southern California’s Alzheimer’s disease and Alzheimer’s
disease Related Dementias Resource Center for Minority Aging Research (USC AD/ADRD RCMAR) brings a
distinct capacity for integrating theories and tools from myriad disciplines including but not limited to economics,
sociology, and gerontology, using large, complex data sets, and applying rigorous panel data and quasi-
experimental methods to generate innovative AD/ADRD disparities research. Our interdisciplinary faculty have
the support and expertise to advance research in our focus area: pathways by which social, behavioral and
economic factors, and policies and health systems affect disparities in risk of AD/ADRD, and affect disparities in
the health, health care and economic outcomes of persons living with dementia. We build upon our successful
10-year history of advancing the research and careers of underrepresented scholars. We bring together the
infrastructure, leadership, interdisciplinary expertise and resources to: (1) increase the number, diversity, and
scholarly achievements of scholars of dementia health equity research and; (2) develop new, innovative lines of
research to advance dementia health equity. The USC AD/ADRD RCMAR is housed in the Schaeffer Center for
Health Policy and Economics, which brings together expertise in AD/ADRD from across USC’s schools, and
maintains a large data core, analytical programming team, and external affairs team to support AD/ADRD
research and disseminate findings for impact. To this we add resources and leaders from our partner NIA funded
centers: USC’s Roybal Center for Behavioral Interventions of Aging, Alzheimer Disease Research Center,
Center for Economic and Sociodemographic Study of AD/ADRD, and USC/UCLA Center on Biodemography
and Population Health. Importantly we have partnered with two HBCUs, Spelman College and Howard
University, and California State University Fullerton - an Hispanic and Latinx serving institution. Their junior
researchers and senior scholars and leaders are uniquely positioned to bring diverse perspectives and broaden
the field of AD/ADRD research. We propose an Analysis Core (AnC) that leverages the deep expertise of
our Investigators and rich resources of programs at USC to provide data and programming support and
offer workshops in sophisticated analytical methods to scientists; to expand on existing and develop
new lines of research and methods to advance dementia health equity; and to promote research and
methods across RCMARs.